Detecting presymptomatic disease in inherited frontotemporal dementia

Project Summary/Abstract This is an application for a K23 award for Dr. Suzee Lee, a behavioral neurologist at the University of California, San Francisco (UCSF). Dr. Lee is establishing herself as a young investigator in patient-oriented clinical research of neurodegenerative disorders. This K23 award will provide Dr. Lee with the support necessary to accomplish the following goals: (1) to become an expert at patient-oriented clinical research in frontotemporal dementia (FTD); (2) to conduct clinical investigations of presymptomatic carriers of genes implicated in FTD; (3) to implement novel and advanced neuroimaging techniques in clinical studies; and (4) to develop an independent clinical research career. To achieve these goals, Dr. Lee has assembled a mentoring team comprised of two co-primary mentors. Dr. Bruce Miller, clinical director of the UCSF Memory and Aging Center (MAC), directs a program project grant on FTD (FTD-PPG) and a Hillblom Aging Network grant to study normal aging. Dr. William Seeley, director the UCSF MAC Autopsy Program and the Neuropathology Core, conducts neuroimaging studies on selective vulnerability in neurodegenerative diseases to explore early-stage disease pathogenesis. The mentoring team also includes two collaborators: Dr. Maria-Luisa Gorno-Tempini, a neurologist who focuses on neuroimaging in primary progressive aphasia and Dr. John Neuhaus, a statistician, who is an expert in study design and biostatistical analysis. Early diagnosis of frontotemporal dementia is notoriously challenging. Dr. Lee's research will focus on detecting vulnerable brain networks in presymptomatic carriers of FTD gene mutations (Aims 1 and 2). Dr. Lee will use the existing infrastructure and subject cohorts of the FTD-PPG and Hillblom Aging Network to study 50 unaffected family members of probands with FTD to determine the effect of FTD-related genes on alterations in large-scale structural and functional connectivity neural networks. This research will be the first step in a series of investigations that will aid the longitudinal characterization of the natural history of FTD from its earliest stages, paving the way for the field to establish disease monitoring strategies and time points for future treatments in gene mutation carriers.

Public health relevance
Project Narrative Improved understanding of when and where in the brain neurodegeneration begins in presymptomatic carriers of frontotemporal dementia genes is critical to early diagnosis and disease-monitoring. Characterizing the history of frontotemporal dementia in this way will be crucial for the successful implementation of future treatments of this disease. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Major recent progress in the genetics and molecular biology of frontotemporal dementia (FTD) has led to new hopes for treatments, particularly for genetic forms of FTD, where gene carriers can be identified before disease onset. Two fundamental, unanswered questions important for future implementation of treatments are when and where FTD begins. Highly penetrant disease-causing mutations exist in the microtubule associated protein tau (MAPT) and progranulin (GRN) genes. Patients harboring these mutations provide the only opportunity to explore pre-clinical FTD. Understanding brain network disruptions occurring before symptom onset will prove essential for identifying vulnerable cells and metabolic processes and for deciding when treatment should begin for individuals at risk. Our long-term goal is to characterize the natural history of inherited FTD prior to symptom onset. This knowledge wil make possible rational decisions regarding when treatment should begin and what imaging biomarkers can be used to follow treatment. The overall objective of this project, with these aims in mind, is to detect vulnerable networks in presymptomatic individuals with FTD gene mutations. Our central hypothesis is that carriers of FTD gene mutations will show alterations within functionally connected, FTD-relevant brain networks that predate both symptom onset and structural gray and white matter changes. Our hypothesis is based on recent progress in network-based dementia neuroimaging, which suggests that "resting-state" or "intrinsic" functional connectivity MRI (fcMRI) can detect large-scale neural network abnormalities in early-stage neurodegenerative disease. Contributing to this emerging literature, Co-Mentor, Dr. William Seeley has shown the relevance of network analysis methods for understanding FTD (Seeley et al., 2009), which targets networks tasked with processing visceroautonomic salience and semantic meaning, functions that decline in FTD. Our preliminary data suggest that fcMRI detects connectivity alterations within FTD-relevant networks in presymptomatic gene carriers compared with their non-carrier family members (see Preliminary Studies, C.2.a) and that these functional changes occur in the absence of structural connectivity disruption (as assessed with diffusion tensor imaging, DTI) or gray matter atrophy (as assessed with voxel- based morphometry, VBM). The rationale for the proposed research is that characterizing preclinical changes in vulnerable brain networks among FTD gene mutation carriers will provide novel insights into the early pathophysiology of FTD and lay the groundwork for future longitudinal observational studies and clinical trials in FTD families. We will test our central hypotheses by pursuing the following specific aims: [Aim 1: To identify network connectivity alterations in presymptomatic FTD gene carriers using fcMRI.] Hypothesis 1a: Overall, MAPT and GRN carriers will have abnormal connectivity in the networks tasked with processing visceroautonomic salience, task control, and semantic meaning. [Hypothesis 1b: MAPT cariers wil have greater disruption within the semantic meaning network, whereas GRN carriers will show greater disruption within the task control network.] [Aim 2: To probe for differences in white matter microstructural integrity in presymptomatic FTD gene carriers using DTI. Hypothesis 2a: Coresponding deterioration in white mater microstructural integrity between regions of reduced functional connectivity in gene carriers will be detectable in a subset of MAPT and GRN mutation carriers with the shortest estimated time to symptom onset. Hypothesis 2b: The sensitivity of fcMRI to detect alterations in network connectivity will be greater than DTI.] Relevance to Career Development Plan: My plan is to become an independent clinical investigator, able to conduct clinical and imaging research in neurodegenerative conditions. Both aims will provide me with strong clinical research experience and neuroimaging training with fcMRI and DTI. !